Multimodal Assessment of Cannabinoid Target Engagement in Adults with Obsessive-Compulsive Disorder

PROJECT SUMMARY/ABSTRACT
Obsessive-compulsive disorder (OCD) is a disabling illness affecting about 4.2 million Americans,4 and current
treatments including serotonin reuptake inhibitors and cognitive behavioral therapy with exposure and response
prevention (EX/RP) will help fewer than 50% of patients achieve remission. This goal of this K23 Award is to
promote Dr. Kayser’s development into an independent physician-investigator who applies an experimental
medicine approach to develop new treatments for severe mental illnesses like OCD. The activities proposed
herein focus on the endocannabinoid system (ECS) as a potential new area for developing OCD treatments and
a model system from which to gain experience in experimental medicine research. Preclinical data implicate the
ECS in OCD-relevant neurocognitive processes (i.e., threat response,5,6 fear extinction learning,7,8,17–21,9–16 and
the balance between goal-directed and habitual behavior22,23), which could be modulated by cannabinoids to
therapeutic benefit. As a T32 fellow, Dr. Kayser began to explore this premise in preliminary studies, showing
that a) smoked cannabis alone did not affect OCD symptoms and b) nabilone, an FDA-approved synthetic
analogue of ∆-9-tetrahydrocannabinol (THC, the primary psychoactive component of cannabis), had no effect as
monotherapy but enhanced the effectiveness of EX/RP when both treatments were combined.3 This leads to the
hypothesis that nabilone may have facilitated fear extinction, which is thought to occur during EX/RP, since
imaging studies of healthy adults show that THC enhances extinction learning by modulating activity in parts of
the brain’s fear network.16,17,21,24 Dr. Kayser’s K23 research project will test this hypothesis using an
experimental medicine design to evaluate how a single dose of nabilone vs. placebo affects OCD-relevant targets
at the neural (e.g. fMRI), physiological (e.g. skin conductance response, electromyography), and psychological
(e.g. behavioral response) level in 60 unmedicated adults with OCD. His K23 training plan will capitalize on
an outstanding research environment and multidisciplinary mentorship team and enable him to develop skills
in (a) clinical trial design, (b) experimental medicine methods, c) translational neuroscience techniques, d)
advanced biostatistical analyses, and e) grantwriting, research presentation, and manuscript preparation.
Hands-on experience from designing and conducting the study will support the above training goals and provide
preliminary data to support a future R61/R33 application. In addition to expanding current knowledge of the
ECS’ role in OCD, study results could provide a mechanistic explanation for nabilone’s effects in OCD and identify
biomarkers to index the effects of nabilone and other cannabinoids in future trials. This research direction may
ultimately yield new treatments for OCD. Moreover, the experiences this K23 supports will foster Dr. Kayser’s
transition to an independent research career focused on developing novel, neuroscientifically-informed
treatments for patients with OCD and other severe psychiatric illnesses.

Public health relevance
PROJECT NARRATIVE Obsessive-compulsive disorder (OCD) is a disabling illness affecting about 4.2 million Americans for which current treatments help fewer than 50% of patients achieve wellness (i.e. experience minimal symptoms), and emerging evidence points to the brain’s endocannabinoid system (ECS) as a possible new area for treatment development. This experimental medicine study will use multiple translational measures (fMRI, skin conductance response, electromyography, behavioral response) to evaluate the effects of nabilone, an FDA- approved cannabinoid medication, on OCD-relevant neural, physiological, and psychological targets in 60 unmedicated adults with OCD. Results may provide a mechanistic explanation for nabilone’s effects, could identify biomarkers to index the effects of cannabinoids in future studies, and may yield new treatment strategies for OCD.